Reduction of risk factors for Obesity and linked Chronic Diseases in Native American employees of the Twin Arrows Casino through a culturally-relevant micronutrient-dense plant-rich (mNDPR) dietary in

Native Americans are 50% more likely to be obese compared with non-Hispanic Whites and are twice as likely to be diagnosed with diabetes. Obesity and poor diet quality are major risk factors for developing Type II diabetes, and Native Americans are disproportionately impacted by poor physical health outcomes. We propose to develop a culturally-relevant micronutrient-dense plant-rich (mNDPR) dietary protocol, which we will then use in a pilot, randomly-controlled trial (RCT) to test the effectiveness of improving health and wellness of Native American employees of Twin Arrows Casino. This study will train and employ Native American students of Northern Arizona University (NAU) to implement our protocol and serve as Lifestyle coaches for the intervention. We hypothesize that the protocol will be effective in (i) improving anthropometric measures (weight, waist circumference), cardiometabolic measures (cholesterol, triglycerides, blood glucose, hemoglobin A1c (HbA1c), fasting insulin, hsCRP, IgF-1, and blood pressure), and wellness measures (anxiety, stress, sleep quality, depressive symptoms, and mood); and (ii) reducing healthcare costs in Native American employees of Twin Arrows Casino over a 1- year period. Consistent with the specified aims of the National Institute on Minority Health and Health Disparities, this project will address health and wellness issues in an underserved population that is disproportionately affected by obesity and related diseases. Consistent with the specified objectives of the Academic Enhancement Research Award, this project will significantly increase research opportunities for students in the Health Sciences, providing the expertise and experience needed to develop skills and advance their careers. Employees of the Twin Arrows Casino will be randomly assigned to a 12-week in-person experimental group or a wait-list control group that will be assigned a start-date 12 weeks after the experimental group. Both groups will undergo the same measures of health and wellness at study week 0 (baseline) and week 13 (post-intervention for the experimental group). During week 26 (the experimental group will undergo follow-up diet analysis and the wait-list control will undergo all measures of health and wellness). Healthcare utilization data will be collected at week 52 for both groups. Statistically significant differences between the intervention and control at the end of the first 12 weeks, as well as differences between baseline and post-intervention outcomes for both groups, will demonstrate the effectiveness of this program in reducing risk factors for obesity and related diseases in Native American employees. Health-care costs of both groups will also be evaluated and significant differences will suggest cost-effectiveness of the program.

Public health relevance
Project Narrative Obesity and related diseases present a health crisis amongst individuals of all ethnicities, and especially amongst Native American populations, of whom 42% are obese and 19.4% have diabetes. In our previous studies, we have shown that a mNDPR dietary program significantly decreased risk factors for obesity, related chronic diseases, and health-care expenditures in multi- ethnic (primarily Non-Hispanic White) individuals. This study aims to broaden these findings, and to provide education and exposure to a culturally-relevant micronutrient-dense plant-rich (mNDPR) dietary program, with a goal to significantly decrease risk factors for obesity and related diseases, as well as reduce health-care costs, amongst Native American employees.